Novel filtration devices for iAs reduction

ABSTRACT: PROJECT 4
Approximately 15% of the United States population, and 25% of North Carolinians, rely on private wells as their
drinking water source. Private wells are not regulated under the Safe Drinking Water Act and therefore their use
as drinking water sources carries increased risk of exposure to waterborne contaminants such as inorganic
arsenic (iAs). Long-term exposure to iAs has been linked to adverse health outcomes such as cancer, diabetes,
and cognitive deficits in children. To limit adverse health outcomes, the US Environmental Protection Agency
(EPA) established a drinking water maximum contaminant level (MCL) of 10 g/L and a maximum contaminant
level goal (MCLG) of zero. However, approximately 2.1 million people in the US drink water from private wells
contaminated with iAs above the MCL, with concentrations as high as 800 µg/L in NC. The US EPA and NC
Department of Health and Human Services (DHHS) recommend pressure-driven reverse osmosis (RO)
membrane filtration to remove iAs from well water because RO requires the fewest chemicals and steps to
remove iAs and is easy to implement. However, application of RO for iAs removal has two primary challenges:
(i) RO inadequately removes As(III) (i.e., the most hazardous iAs species) despite removing As(V) effectively,
and (ii) RO suffers of low water productivity (e.g. under-the-sink RO systems purify only ~15% of the input water).
The goal of Project 4 is to develop a novel membrane technology that addresses these two fundamental
challenges in current membranes for iAs removal. We hypothesize that novel (patent pending) pressure-
driven membranes endowed with electrically conductive properties will enable the simultaneous
increase of water productivity and iAs removal, particularly of As(III), without chemical pretreatment. Our
hypothesis is supported by initial findings showing that we can use our platform method for fabrication of
electrically conductive membranes (ECMs) to develop ECMs with a broad range of performance that can
simultaneously oxidize As(III) into As(V) and remove iAs. We will accomplish our goals via three specific aims:
(1) Develop scalable ECMs with greater iAs removal and water productivity than currently available commercial
RO membranes; (2) Elucidate iAs transport mechanisms in ECMs; and (3) Compare ECM performance to that
of a benchmark RO membrane using a range of NC private well water samples and prolonged operation at pilot
scale. Project 4 addresses the theme of the UNC-SRP "Protecting vulnerable populations from arsenic-induced
metabolic dysfunction with a vision for exposure reduction and disease prevention" and is responsive to
Mandates 3 and 4 of the NIEHS SRP as it focuses on advanced methodologies to detect hazardous substances
in the environment and methods that reduce the amount and toxicity of toxic substances in the environment. The
proposed work is significant and innovative, as it will develop novel membrane technology to reduce exposure
to iAs and elucidate fundamental understanding of transport in ECMs to enable continued ECM optimization.

Public health relevance
NARRATIVE: PROJECT 4 Approximately 2.1 million people in the US drink water from private wells contaminated with iAs at concentrations above the US EPA maximum contaminant level of 10 ug/L, with concentrations as high as 800 µg/L in North Carolina. Pressure-driven reverse osmosis (RO) filtration is commonly used for filtration of iAs-impacted well water, but RO suffers from low water productivity and inadequately removes the most hazardous iAs species (As(III)) without chemical pretreatment. Project 4 will address these two fundamental challenges of RO technology through its overall goal of developing novel electrically conductive pressure-driven membranes (patent pending) that enable the simultaneous increase of water productivity and iAs removal, particularly of As(III), without chemical pretreatment.